Structure-activity relationships governing mammalian SWI/SNF chromatin remodeling activity as a function of chromatin state

PROJECT SUMMARY
Recent whole-exome sequencing studies in human cancer and neurodevelopmental disorders have unmasked
frequent mutations in genes encoding chromatin regulatory proteins. Specifically, genes encoding subunits of
the mammalian SWI/SNF ATP-dependent chromatin remodeling complexes (also called mSWI/SNF or BAF
complexes) are perturbed in over 20% of malignancies, underscoring their critical roles in the maintenance of
timely and appropriate gene expression. The mechanisms by which mSWI/SNF family complexes are targeted
on chromatin and the features of the histone landscape that govern their activities remain unknown. Indeed, a
systematic evaluation defining the contributions of specific histone landscape features to canonical BAF, PBAF,
and non-canonical BAF complex targeting and activity would represent a significant advancement in the field at-
large. Here we aim to: (1) Determine the genome-wide targeting of distinct, final-form mSWI/SNF complexes in
human cells and the impact of select cancer-associated complex perturbations; (2) Define the in vitro
nucleosome remodeling and ATPase activities of endogenously-purified mSWI/SNF subcomplexes, BAF, PBAF,
and ncBAF, in wild-type (WT) and mutant states; and (3) Determine the impact of core histone variants and
histone tail modifications on mSWI/SNF complex nucleosome binding and activity. Taken together, successful
completion of these aims centered at the intersection of biochemistry, epigenetics, and cancer biology, will
constitute a highly timely series of advances in the field of chromatin biology, and will contribute important
knowledge regarding the mechanism of targeting of mSWI/SNF complexes across a range of both normal and
oncogenic states. Given that a major impediment to the development of on-target modulatory agents of
mSWI/SNF complexes lies in the lack of biological understanding of complex-specific targeting and functional
regulation, the results of this proposal are likely to provide the basis for new approaches toward targeted
disruption of mSWI/SNF-chromatin interactions.

Public health relevance
PROJECT NARRATIVE Mammalian SWI/SNF ATP-dependent chromatin remodeling complexes are multi-subunit macromolecular machines that play critical roles in the regulation of chromatin architecture. However, the mechanisms by which mSWI/SNF complexes target to specific sites and engage specific features of the chromatin landscape genome- wide, and how these binding interactions impact catalytic activity remain unknown. Owing to their frequent perturbation in human disease, with genes mutated in >20% of human cancers and several intellectual disability syndromes, defining the mechanisms governing mSWI/SNF targeting and activity will enable an understanding of disease-specific biology and may provide a powerful foundation for the identification of new therapeutic strategies.